GPCR biology in autoimmunity: bridging genetics to structure to decipher mechanisms of disease

PROJECT SUMMARY/ABSTRACT
Genome-wide association studies have implicated multiple genetic variants of G-protein coupled receptors
(GPCRs) in immune-mediated diseases. Translating genetic associations into tangible effects on protein function
remains a significant challenge. Here, we will leverage advancements in biophysics and structural biology to
discern how coding variants in prioritized GPCRs alter structure, function, and downstream signaling. Insights
from these studies will be used to devise therapeutic hypotheses and to test experimental interventions that
target genetic mechanisms of disease. Specifically, we will (1) Define the structural basis for impaired function
of the autoimmunity-associated GPR65 variant and rescue by positive allosteric modulators, (2) Define the
structural basis for autoimmunity-associated PTAFR variant and its gain-of-function mechanism, and (3)
Discover novel GPCR variants and integrate genetics with functional mutagenesis to define mechanisms of
disease. Overall, we propose to combine genetics and structural biology approaches to expand on a foundation
for pharmacologic strategies targeting GPCRs in autoimmune disease.

Public health relevance
PROJECT NARRATIVE Advancements in human genetics have opened new opportunities to discern the molecular mechanisms underlying common human diseases; for example, genetic variants in G-protein-coupled receptors (GPCRs) have been implicated in a variety of immune-mediated diseases that impact organ systems across the body. Here, we propose a “genetics first” approach combined with cutting edge structural biology techniques to define the biochemical basis for GPCR dysfunction in autoimmunity. Insights from these studies will be leveraged to guide the development of therapeutic strategies aimed at addressing the causal mechanisms of disease.